Genomes in 3D: from maps to mechanisms

Project Summary
In each of our trillions of cells, genetic information is stored on meter-long chromosomes spatially organized
inside micron-scale nuclei. In the past decade, large-scale efforts have built increasingly detailed atlases of
transcription, regulatory elements, and genome folding across ever-expanding sets of cell types and tissues.
Still, these beautiful maps do not by themselves reveal the sequences or molecular mechanisms acting in
these diverse cellular contexts. Drawing on approaches from biophysics, bioinformatics, and machine learning,
this project will develop novel computational approaches to determine the DNA sequences and mechanisms
underlying 3D genome organization, and how this in turn relates to genomic functions. Drawing on the latest
breakthroughs in machine learning, we will model how individual nucleotides contribute to genome folding. We
will apply these models to characterize cell-type specific genome folding, develop methods to engineer DNA
sequences in silico, and model enhancer-promoter influences. Concurrently, we will build biophysical models
to understand deeply conserved mechanisms of genome folding. Using meiotic chromosome folding as a
model system, we will develop models to learn new rules governing cohesin dynamics and loop extrusion. To
uncover how extrusion interfaces with other mechanisms, we will build models of synaptonemal complex
assembly, as well as models of meiotic chromosome organization across species. By honing in on the
sequences most crucial for locus-specific genome folding and characterizing the mechanisms driving genome-
wide folding, the computational models we develop and the mechanisms we discover will enable new
approaches to precision genome engineering. This will include how to re-wire gene-regulatory circuits, not only
by targeting enhancers and promoters, but also by modulating their cell-type specific communication. At the
same time, the aims described here will bridge fundamental insights into 3D chromosome organization with
clinical genomics, and greatly improve the interpretability of non-coding DNA variants.

Public health relevance
Project Narrative Non-coding DNA sequences play crucial roles in gene regulation and the physical organization of the genome, with roles in development and consequences for disease. Using novel biophysical modeling and machine- learning approaches, this project will connect fundamental insights into 3D genome organization with the functional consequences of its disruption. These insights into genome organization will both aid in determining potentially pathogenic genetic variants, and open new frontiers in precision genome engineering.